DEVELOPMENT OF IN VITRO DIAGNOSTICS FOR ANTIMICROBIAL RESISTANCE ESCHERICHIA COLI

To support the development of promising diagnostics technologies for antimicrobial-resistant infections, emerging and reemerging infectious diseases and biodefense pathogens. Areas of support may focus on improving performance of agnostic nucleic acid sequencing solutions on commercial platforms; methods that improve protein analyte detection; and efforts to improve direct-from-blood or other biofluid detection and identification of microbial infection.